Leukocyte Adhesion Receptors Mac-1 and P150,95

DESCRIPTION (provided by applicant): The leukocyte integrins αXβ2 and αMβ2 are important in inflammatory responses of myeloid and dendritic cells. They bind a range of ligands including iC3b, and are complement receptors CR4 and CR3. Upon cell activation, integrins change shape and bind ligand (inside-out signaling). Understanding the molecular basis of this structural alteration is of great importance. The long-term goal of this application is to understand at the atomic level 1) how allostery in αMβ2 and αXβ2 is transmitted from the juxtamembrane regions through the lower legs, upper legs, and βI domain, to the ligand-binding αI domain, 2) how ligands such as iC3b bind, 3) how small molecule antagonists inhibit ligand binding by disrupting allostery, and 4) how ligand binding and conformation are regulated in terms of the energetics of different conformational states. This proposal builds on our previous progress in determining crystal and EM structures of αXβ2, EM structures of the complement component C3 and its products, and EM structures of αXβ2 bound to iC3b and C3c. A new crystal form of the bent αXβ2 ectodomain will be characterized, in which the αX I domain is open, αX Glu-318 binds to the β2 I MIDAS and other residues move out of contact with βI and reshape to form an intrinsic ligand structure. The β2 I domain shifts to an intermediate state. The crystal structure of an αXβ2 headpiece with an αI-open/βI- open conformation will reveal βI opening and hybrid domain swing-out. Mutational studies will examine the α- and β-genus, features that regulate αI-βI signal relay, Gly residues in the βI α1-helix, an ?I linker disulfide, and specific structural features that regulate the equilibrium between integrin conformational states. Basis for selectivity of αXβ2 for iC3b versus other complement products will be examined using surface plasmon resonance with high affinity mutant αXβ2. The basis of affinity regulation, and the energetics of different αXβ2 conformational states, will be examined by employing different mutations, and measuring affinities for ligand and six Fab specific for the closed headpiece, open headpiece, or extended conformations. Finally, the structure of the αXβ2 headpiece bound to C3c will reveal the basis for specific ligand recognition and selectivity of αXβ2 for iC3b.

Public health relevance
PUBLIC HEALTH RELEVANCE: Leukocyte integrins are important in defense against infection. This grant deepens our understanding of their structure and function, and is enabling for treatment of disease and improvement of therapeutics for autoimmune and inflammatory diseases.